Early Puberty During the COVID-19 Pandemic in a Multi-Ethnic, Population-Based Cohort of Children and Adolescents

PROJECT SUMMARY
Early puberty is associated with adverse health outcomes over the life course, including psychopathology
in adolescence, and reproductive cancers, diabetes, and cardiovascular disease in adulthood. The age of
pubertal onset has declined dramatically over the past 40 years in the United States (US), with alarming
racial/ethnic disparities. These disparities may amplify future health inequities in chronic conditions, yet remain
poorly understood. During the COVID-19 pandemic, pediatric endocrinology centers across twelve countries
reported large increases in the incidence of central precocious puberty (CPP), a rare condition characterized by
developing secondary sexual characteristics before age eight in girls and nine in boys. However, existing studies
are subject to limitations such as small samples from specialty care settings, insufficient power to examine trends
in boys, and reliance on diagnostic criteria for CPP. In addition to CPP, it is important to examine normative
timing of early pubertal milestones, including onset of pubic hair and breasts/testes development, because they
represent the earliest observable markers of underlying hormones and may play differential roles in the etiology
of health outcomes. Moreover, no studies have investigated whether the pandemic exacerbated pre-existing
racial/ethnic or neighborhood-level disparities in pubertal timing. To fill gaps in current knowledge, this study will
leverage electronic health records from Kaiser Permanente Northern California (KPNC) to conduct the first
population-based study on the pandemic and pubertal timing in the US. KPNC comprises ~32% of the northern
California population and has 4.4 million members. In 2010, KPNC began systematically documenting routine
pubertal development assessments for all children aged 6 years and older, thereby facilitating the study of trends
in both CPP incidence and normative pubertal timing in a population with considerable racial/ethnic,
socioeconomic, and geographic diversity. First, we will estimate pre–post pandemic changes in incident CPP
diagnoses at KPNC medical centers using an interrupted time series design, using data from 2017–2023 (Aim
1). Second, we will use survival analysis techniques to estimate pre–post pandemic changes in the timing of
normative pubertal milestones (including onset of pubic hair development, breast/testes development, and
menses) in a representative population cohort of approximately 103,000 boys and 72,000 girls (Aim 2). Finally,
we will examine the differential impact of the pandemic on CPP and normative pubertal timing across diverse
racial/ethnic groups and neighborhood conditions (Aim 3). Study strengths and innovations include the use of a
robust quasi-experimental design, longitudinal assessment of a large and representative population of boys and
girls, and investigation of several important hallmarks of puberty. Examination of racial/ethnic and place-based
disparities will guide the design of upstream health equity interventions and inform both clinical practice and
future pandemic response. This study also provides a foundation for future research to determine whether earlier
puberty has lasting health consequences for today’s children as they transition to adulthood.

Public health relevance
PROJECT NARRATIVE Early puberty increases the risk of adverse health outcomes over the life course, including mental health conditions, diabetes, cancer, and cardiovascular disease. During the COVID-19 pandemic, pediatric endocrinology centers across several countries reported large increases in early puberty diagnoses; however, there is currently no epidemiologic data on pandemic-related changes in early puberty in the United States. Using electronic health records from the nation’s largest integrated healthcare system, this study will assess pre–post pandemic changes in precocious puberty diagnoses and timing of pubertal milestones in the general population, with a focus on identifying subgroups most impacted by these changes to inform health equity initiatives and future pandemic response.